Rhode Island IDeA Network of Biomedical Research Excellence

Project Summary for the Centralized Research Core Facility (CRCF) Core
The Centralized Research Core Facility (CRCF: “Instrument Core”) Core provides RI-INBRE investigators, as
well as investigators throughout the state of Rhode Island, with access to state-of-the-art, specialized biomedical
instrumentation that typically could not be purchased by individual new investigators. The Instrument Core
contains equipment in several categories, including: mass spectrometry, spectroscopy, proteomics, mammalian
tissue culture, and imaging. During the renewal period, the Instrument Core will continue to train users at all
academic levels on instrument usage and capabilities. We will strategically add to the Core instrumentation to
primarily support research conducted in the three RI-INBRE programmatic areas: cancer, neuroscience, and
environmental health sciences. The scope of the Instrument Core will also be broadened to include oversight of
RI-INBRE instrumentation at the network institutions. We will ensure that the Core instrumentation and expertise
is readily accessible to both RI-INBRE network and non-network investigators. We will also partner with the
network Primarily Undergraduate Institutions (PUIs) and the Community College of Rhode Island (CCRI) to
incorporate the Core resources and expertise into curricular development. During the renewal period, we will
increase Core usage and broaden the impact of the Instrument Core and promote statewide inter-disciplinary
and inter-institutional collaboration.

Public health relevance
Narrative for CRCF Core is not applicable.